Paper-based cultures supporting tissue-like structures for biochemical studies of oxygen gradients and screening applications

Project Abstract: Lockett, Matthew Ryen
Despite the importance gradients play in regulating tissue formation, structure, and homeostasis there are
few analytical tools capable of generating tissue-like environments with experimentally defined oxygen gradi-
ents. The tools that are available have not been widely adopted by tissue culture laboratories because they
require specialized equipment and engineering expertise to setup, maintain, and analyze. To enable the study
of oxygen’s role in directing responses at the cellular, tissue, and organ level new culture platforms are need-
ed. My laboratory has been developing a paper-based culture platform for the last four years. This platform is
unlike any other. Employing simple technological solutions, we can readily generate 3D cultures with defined
extracellular environments, regardless of cell type or tissue structure. The level of experimental control afford-
ed by the paper culture platform, makes them a powerful enabling technology to probe cellular responses in
well-defined extracellular environments
This MIRA application builds upon our prior successes and continues to innovate the paper platform. In par-
ticular, we will leverage our ability to generate defined extracellular gradients to study the role of oxygen in
regulating cellular phenotype, modulating protein expression and activity, and promoting directed movement.
The diffusion-dominated gradients formed in our platform are similar to those that form in healthy tissue, and
we are able to generate both healthy tissue environments as well as those resulting from ischemia or poor
vascularization. In particular we will: 1) Develop tools to characterize the gradients that form in the paper cul-
tures, focusing on oxygen, pH, glucose, and lactate. Through the use of luminescent extracellular, intracellular,
and transcription-based sensors we will determine the design rules to generate gradients on demand. Such
design rules will help others interested in studying particular aspects of the tissue microenvironment. 2) Evalu-
ate differences between immotile and highly invasive cells. These datasets will shed light on the microenvi-
ronment’s role—in particular oxygen gradients—in promoting varied cellular responses that result in move-
ment, drug resistance, etc. 3) Generate tissue-like co-cultures with physiologically relevant oxygen gradients.
By generating liver and breast lumen models, we will be able to experimentally determine how oxygen gradi-
ents lead to zonation (liver) and regulate hormone receptor activity (breast). 4) Develop a platform to screen
multiple 3D tissue structures in parallel. The ability to generate and evaluate many tissue structures in parallel
will greatly improve screening processes to assess liver toxicity and identify potential endocrine disruptors.

Public health relevance
Project Narrative: Lockett, Matthew Ryen Gradients of oxygen are ubiquitous in tissue biology and known to regulate metabolism, cellu- lar phenotypes, and direct movement. Despite the importance of oxygen, there are a limited number of tools able to impose experimentally defined extracellular gradients across tissue- or organ-like structures. This MIRA application builds on the readily accessible 3D culture plat- form we are developing, to 1) study fundamental cellular regulation in oxygen gradients and 2) generate multi-tissue structures to screen cellular responses to potential toxicants.